Mechanism of Epigenetic Inheritance

Abstract
In eukaryotic cells, genomic DNA is packaged into chromatin that encodes epigenetic information and maintain
genome integrity. Chromatin is further organized into distinct functional domains, such as heterochromatin and
euchromatin, that contain different post-translational histone modifications (PTM). How different chromatin
states are inherited during S phase of the cell cycle is one of the most challenging questions in the
chromatin and epigenetic fields. The “first” step in this complex process is the assembly of replicated DNA into
nucleosomes using both parental and newly-synthesized histones in a process that is tightly coupled to ongoing
DNA synthesis. We have been studying how nucleosomes are formed following DNA replication and have
made multiple major contributions to this process. However, how parental histone (H3-H4)2 tetramers, the
primary carrier of epigenetic modifications, are transferred to replicating DNA is still poorly understood, which
hinders our understanding of the transmission of epigenetic information into daughter cells. The major
challenge to understanding parental histone (H3-H4)2 assembly is a lack of methods to track this
process. We have developed the eSPAN (enrichment and Sequencing Protein- Associated Nascent DNA)
method that can discern whether a protein binds to leading or lagging strands of DNA replication forks in both
yeast and mouse embryonic stem (ES) cells. This method makes it possible to identify factors that function in
nucleosome assembly of parental histone (H3-H4)2. Moreover, we discovered that cells defective in parental
histone transfer compromise the repression of endogenous retrovirus (ERVs), repetitive DNA elements that
are normally silenced via a heterochromatin-based mechanism. Others show that ERV reactivation in cancer
cells leads to increased response to immunotherapy. In this proposal, we will elucidate the molecular
mechanisms whereby parental (H3-H4)2 are reassembled into nucleosomes following DNA replication in yeast
and mouse ES cells and determine how deficiencies in this process impact ERV silencing. Together, these
studies will address fundamental questions regarding chromatin replication and epigenetic inheritance, while
also providing novel insights into a major epigenetic mechanism that boosts the response of cancer cells to
immunotherapy.

Public health relevance
Project Narrative We are requesting Supplement to cover the cost of purchasing a PowerEdge R750XA server from Dell, which will be used daily by personnel in the laboratory for bioinformatic analysis, for protein structural determination and prediction using Cryo-EM and Alpha-fold 2, thereby facilitating successful completion of the proposed studies.